Platelet- mast cell interactions as determinants of the vascular pathology in septic shock.

Abstract:
Development of shock in sepsis defines a dramatic deterioration of clinical status and is linked to a significant
increase in morbidity and mortality rates. However, the cellular and molecular mechanisms determining the
vascular pathology of septic shock remain undefined.
Our past work established mast cells (MC) as key effector cells of vascular pathology in different
disease contexts. Because MC products are found in the plasma in shock but not during sepsis, this supports
that MC activation is a central event leading to septic shock. Employing state-of-the- art technologies such as
dynamic photoacoustic imaging of the microvasculature, we provide first evidence that MCs shape key features
of shock in sepsis: systemic hypotension, vascular leakage and microvascular perfusion abnormalities. In
addition, we elucidate that in sepsis MCs, which are located on the abluminal side of a relatively
impermeable endothelium, are stimulated by platelets, which can aggregate in their close proximity following
inflammatory triggers.
Based on these observations, we hypothesize that specific signaling interactions between platelets,
perivascular MCs and the endothelium drive the vascular pathology of septic shock. The objective of our work is
first to comprehensively define the mechanisms of MC-mediated vascular pathology in sepsis, second to
elucidate the specific mechanism by which platelets trigger MC responses and resultant vascular pathology
and lastly, to establish the clinical relevance of our findings in a cohort of septic patients.
Together, this project constitutes a key step towards our long-term goal to establish MC responses as
a biomarker of sepsis biology and to develop novel therapeutic strategies that may directly target the
mechanisms of disease progression in sepsis.

Public health relevance
Relevance statement: Development of shock marks a critical event in sepsis and is linked to a dramatic increase in morbidity and mortality. Our preliminary data supports that mast cells, which are best known for their ability to launch powerful inflammatory responses in allergy, are shaping key features of vascular pathology in septic shock. By defining platelets as the circulating source of mast cell activation and by examining the relevance of mast cell activation in septic patients, we will develop a comprehensive picture of the events that shape development of shock in sepsis.